Cellular resolution multi-omics of white matter tracts in developing human and non-human primate brain for cell atlases

Project Summary/Abstract
The molecular evolution underlying cell type diversity and function has facilitated the increased cognitive capacity
of humans. While significant progress has been made to uncover cell type specific gene expression programs
in the brains of rodents, only a modest amount of progress has been made in human brains. Moreover, the
majority of the existing cell type genomic datasets focus on gray matter. Our recent work has identified important
human-specific gene expression patterns relevant to non-neurons, especially oligodendrocytes. Human brain
imaging studies in disorders such as autism spectrum disorders and schizophrenia have identified alterations in
white matter tracts that are primarily comprised of oligodendrocytes. We therefore propose to profile white matter
tracts that are anatomically comparable across primates: pyramidal tract, optic chiasm, cerebellar white matter,
and corpus callosum. Because oligodendrocyte maturation varies between gray and white matter, we will profile
tissue across development. This comparative cell type profiling between human and non-human primate brain
will provide spatially defined epigenomic and transcriptomic data through the following four Aims: 1) Profile single
cell level transcriptional maps and chromatin states of white matter tracts and functionally associated gray matter
in human brain across development; 2) Profile single cell level transcriptional maps and chromatin states of white
matter tracts and functionally associated gray matter across development in two non-human primates: rhesus
macaque and the common marmoset; 3) Profile single cell level transcriptional maps and chromatin states of
white matter tracts and functionally associated gray matter in additional tissue from adult great ape and monkey
brains; and 4) Validate observed differences in white matter composition at the cell type level in human and non-
human primates. Together, these aims will molecularly define understudied cell types from human and non-
human primate brains.

Public health relevance
Project Narrative The human brain is comprised of heterogenous cell types, and understanding the gene expression patterns and chromatin states within each of these cell types will provide important insights into many cognitive disorders. The proposed studies will profile cell types in understudied regions of human and non-human primate brain. The resultant data will contribute to human and non-human primate cell type atlases, as well as identify molecular signatures that distinguish humans from closely related species.